Quantification of the neurocognitive, brain, and blood markers of dementia in middle-aged autistic adults

ABSTRACT/ SUMMARY
This R01 study will apply neurocognitive, brain, and plasma biomarkers to quantify prodromal signs of dementia
in autistic adults ages 40-65. Autism spectrum disorder (ASD) is a lifelong condition that continuously demands
precision diagnosis, targeted treatment, and high-quality care. Emerging clinical and epidemiological studies
suggest that autistic adults are more vulnerable to developing early-onset dementia than the general population
as they age. Robust pilot data from our group show accelerated verbal memory and executive function
deterioration in middle-aged autistic adults. Our free-water diffusion MRI (FWdMRI) data show FW
accumulations in the hippocampal and frontotemporal areas relevant to these behavioral deficits in ASD. Our
amyloid PET scans highlight early amyloid load in Phase 1 (i.e., neocortices) Thal regions and elevated amyloid
burden in Phase 2 (e.g., entorhinal cortex, hippocampus, and amygdala) Thal regions in autistic adults,
accompanied with cortical thinning and volume reductions of these affected areas. Our preliminary plasma
biomarkers also show significant increases in amyloid β42 (Aβ42), Aβ40, total Tau, and neurofilament light chain
(NfL) in autistic adults relative to controls. Despite promising findings from our lab and others, studies focused
on neurodegenerative comorbidities in ASD are scant. We are still far from a systematic understanding of
dementia onset, manifestation, and progression in ASD. To address this critical scientific gap, we plan to acquire
cross-sectional data to quantify established neurocognitive, brain, and plasma biomarkers of dementia in autistic
adults and compare these markers with age- and sex-matched cognitively normal controls. Forty-five autistic
adults and 45 controls ages 40-65 will be recruited. Aim 1 will quantify verbal memory retention and executive
function impairments in ASD. Aim 2 will quantify dementia-related brain degenerations in autistic adults using T1
weighted MRI, FWdMRI, and amyloid PET. Regions of interest will focus on the hippocampus, hippocampal
input and output tracts, and frontotemporal areas. Aim 3 will focus on quantifying plasma
Amyloid/Tau/Neurodegeneration (A/T/N) biomarkers in autistic adults, including Aβ40, Aβ42, Aβ42/Aβ40 ratio,
phosphorylated Tau (pTau), NfL, and glial fibrillary acidic protein (GFAP). The relationships among cognitive
(Aim1), brain (Aim2), and plasma (Aim 3) biomarkers will be explored to achieve a multi-dimensional evaluation
of dementia pathophysiology in ASD. This work holds significant promise to develop a foundational
understanding of the pathophysiological mechanisms underlying dementia in ASD across outcome measures at
multiple levels.

Public health relevance
PROJECT NARRATIVE Autistic adults are more vulnerable to developing early-onset dementia than the general population as they age. This study aims to uniquely quantify dementia-sensitive neurocognitive, brain, and plasma biomarkers in middle- aged autistic adults to reveal pathophysiological mechanisms underlying prodromal dementia in autism spectrum disorder (ASD). The proposed studies will provide foundational insights into dementia pathophysiology in ASD to inform screening, diagnosis, therapeutic plans, and monitoring strategies.